Targeting Small Nucleolar RNA Augments Immunotherapeutic Efficacy

Project Summary
Despite the establishment of obesity as a risk factor in the development of a multitude of cancer types including
breast cancer, there is still a significant insufficiency of genetic evidence for implicating obesity in the initiation
and progression of breast cancer development. While immunotherapeutic approaches such as the PD-1/PD-L1
blockade have shown promise in treating breast cancer, obesity causes substantial impairment of anti-tumor
immunity. A significant challenge in the development of effective immunotherapeutic strategies for obesity-
associated breast cancer lies in the characterization of the bone fide target genes that drive obesity-associated
immune resistance. The emergence of noncoding RNAs as important biological molecules has provided the
foundation for the development of next-generation treatment strategies. Our preliminary data demonstrated that
a small nucleolar RNA (snoRNA), SNORD46, is upregulated in breast cancer and negatively correlated with the
infiltration of cytotoxic leukocytes. We also indicated that obesity is associated with a chromatin variant of
SNORD46. We collected genetic evidence indicating that the expression of SNORD46 leads to obesity and
mammary gland tumors which are resistant to immunotherapy. Therefore, the goal of this proposal is to
comprehensively characterize and implicate SNORD46 as a driver of obesity-associated breast cancer and
demonstrate that targeting snoRNAs effectively improves the expansion and activation of CD8+ T-cells and NK
cells and sensitizes obesity-associate breast cancer in immunotherapy.
We will address our central hypothesis that snoRNAs act as essential gene targets that promote obesity and
obesity-associated breast cancer initiation and immune resistance, which could be attenuated in vivo by an anti-
sense oligonucleotide-based targeted therapy. In Specific Aim 1, we will define the molecular mechanism of
SNORD46 inhibited, IL-15-dependent non-classic pathway in adipocytes, and IL-15-dependent expression of
stimulatory checkpoints in CD8+ T cell and NK cells. In Specific Aim 2, we will ascertain the functional importance
of snoRNAs in obesity-associated tumorigenesis and immune resistance using high-fat diet-induced obese mice
and Snord46 mut/mut knockin obese mice.
The proposed study will provide initial genetic evidence for defining the crucial role of adipocyte-expressed
snoRNAs in promoting obesity and obesity-associated breast cancer. Mechanistically, we will elucidate the
molecular mechanisms of the SNORD46-leukocyte interactions that drive obesity-associated breast cancer
resistance to immunotherapy. Clinically, the proposed studies will delineate that targeting snoRNAs using locked
nucleic acids (LNAs) effectively improves the proliferation/activation of CD8+ T-cells and NK cells in vivo,
sensitizing obesity-associated breast cancer to immune checkpoint blockers.

Public health relevance
Project Narrative Although obesity has previously been established as a significant risk factor in the development of several cancer types (including breast cancer) and resistance to immunotherapy, there is a lack of genetic evidence for directly attributing obesity to the initiation or progression of its associated breast cancer. Noncoding RNAs have recently emerged as key players in a multitude of cellular signaling processes, and preliminary data has suggested that the upregulation of the small nucleolar RNA (snoRNA) SNORD46 is correlated with both increases in body mass index (BMI) and diminished infiltration of cytotoxic leukocytes. Therefore, this proposal will dissect the molecular mechanisms of adipocyte-expressed SNORD46 under obese conditions, implicate SNORD46-leukocyte interactions in driving obesity-associated immune resistance, and assess the efficacy of a SNORD46 LNAs targeted therapy in improving CD8+ T-cell infiltration and sensitizing obesity-associated breast tumors to immunotherapy.